Molecular Logic Sculpting Cell-Specific Contributions of Neurexin-1 at the Tripartite Synapse

ABSTRACT
Substantial evidence implicates copy number variations (CNVs) of the gene encoding Neurexin-1 (Nrxn1), a
synaptic cell adhesion molecule, in the pathoetiology of Autism spectrum disorder, schizophrenia, and Tourette
syndrome. However, very little is known regarding the function and regulation of Nrxn1 at developing and adult
synapses, an understanding of which may improve our knowledge of brain disorders and reveal novel therapeutic
targets. My preliminary data show that Nrxn1 is not only expressed by neurons, but also by astrocytes,
challenging the classical view of Nrxn1 as being exclusively presynaptic. Here, I propose that astrocytic Nrxn1
mediates an important form of communication between astrocytes and synapses that is required for normal
excitatory synapse development and function. My preliminary findings show that astrocytic and neuronal Nrxn1
fundamentally differ in major isoform expression, alternative splicing, and heparan sulfate (HS) modification.
Selective loss of astrocytic Nrxn1 leads to a significant and selective reduction in AMPA receptor (AMPAR)-
mediated synaptic transmission without affecting synapse number in the hippocampus, a brain region important
for consolidation of information from short-term memory to long-term memory and spatial memory. How does
the postsynaptic membrane, which contains numerous neurexin ligands (e.g. LRRTMs, neuroligins, etc.),
distinguish between presynaptic and astrocytic Nrxn1 to allow compartment-specific signaling within the tripartite
synapse? In order to better understand the molecular mechanisms utilized by astrocytic Nrxn1 to instruct
synapse development I will perform rescue experiments in Nrxn1 astrocyte conditional knockout (acKO) mice
using AAVs to deliver Nrxn1 variants differing in major isoform identity, alternative splicing, HS modification, and
intracellular signaling. Recordings of both spontaneous and evoked excitatory synaptic responses will be
performed on CA1 pyramidal neurons to measure rescue efficacy. Next, I will extend our understanding of the
functional consequences of Nrxn1 deletion through studying whether astrocytic Nrxn1 is required for basal and/or
activity-induced changes in dendritic spine morphology and density, as well as the three-dimensional density of
functional AMPARs. Finally, the synaptic deficits observed following deletion of astrocytic Nrxn1 may be a
downstream consequence of impaired astrocyte function. Thus, I will measure several aspects of astrocyte
function following Nrxn1 deletion in astrocytes, including physiological (i.e. membrane properties and channel
currents), morphological (i.e. territory, gap-junction coupling, and association with synapses), and circuit-related
(i.e. calcium dynamics) properties. It is anticipated that the proposed research will provide critical insights into
the molecular and cellular basis of how Nrxn1 CNVs give rise to neurodevelopmental disorders and will shed
light on a novel molecular program underpinning communication between neuronal and astrocytic compartments
of the tripartite synapse.

Public health relevance
PROJECT NARRATIVE Copy number variations in the gene encoding neurexin-1 (Nrxn1), a well-established presynaptic adhesion molecule, have been linked to autism spectrum disorder, schizophrenia, and Tourette syndrome. My preliminary findings show that astrocytes express high levels of Nrxn1 that is molecularly distinct from neuronal Nrxn1 and that regulates excitatory synaptic transmission but not synapse number. This proposal will elucidate the molecular and cellular mechanisms responsible for impaired excitatory synaptic function following loss of astrocytic Nrxn1, which will yield critical insights into how perturbed astrocyte-synapse communication may contribute to neurodevelopmental disorders.